Chemical probes to modulate acyl-homoserine lactone quorum signal synthesis

Abstract
Gram-negative bacteria count specific, N-acyl-L-homoserine lactone (AHL) quorum sensing (QS) signals in
the environment to estimate local population densities, facilitate cell-cell communication and virulence. AHL
synthases make AHL autoinducer signals by enzymatically coupling acyl-ACP/acyl-CoA and S-adenosyl-L-
methionine metabolites to facilitate quorum sensing for the bacterium. Small molecule inhibitors of AHL
synthase enzymes would limit signal synthesis, interrupt quorum sensing and thus hold significant promise
as chemical tools to investigate QS networks in bacteria. Designing AHL synthase-specific inhibitors, however,
does remain a significant challenge. To develop AHL synthase selective inhibitors, we recently embarked on
a proof-of-concept study to evaluate the potential of AHL signal derivatives as product analog inhibitors of
Pseudomonas aeruginosa RhlI AHL synthase. In this study, we demonstrated that AHL analogs could serve
as ‘chemical probes’ to uncover novel inhibition and activation binding pockets that could be tapped to develop
potent AHL synthase-specific modulators. In this grant application, we extend this approach on a broader
scale to evaluate the utility of AHL analog chemical probes in discovering novel binding pockets, determining
the mechanistic basis of AHL synthase modulation, and formulating the rules of AHL engagement in short,
medium and long-chain preferring AHL synthases. Additionally, we will determine how the inhibition and
activation pockets could be leveraged to develop novel substrates and substrate analog inhibitors of AHL
synthases. Successful completion of these studies should inform the rational design of inhibition and activation
pocket directed AHL synthase modulators. Finally, the goals described in this application are tightly aligned
with the objectives of AREA program, which are to a) support meritorious research at an undergraduate
focused institution, b) strengthen the research environment at the home institution and c) provide opportunity
for undergraduate students to get involved in biomedical research.

Public health relevance
PROJECT NARRATIVE STATEMENT Research described in this application will provide foundation data on AHL specificities for a broader array of AHL synthases. This information is critical to evaluate the potential of AHL analogs as chemical probes to discover novel binding pockets and modulators for AHL quorum signal synthases. Small molecules that modulate quorum sensing will provide new and valuable tools to physicians to reduce infection rate and defeat multi-drug resistant organisms.